R15 AREA: Optimizing allosteric modulation of noncoding regulatory RNA function

Project Summary
Bacterial drug resistance is a significant global health threat that has turned once treatable
bacterial infections (including Gram-positive infections) into deadly illnesses. To overcome this
serious threat to human health, completely novel antibiotics are needed. The T-box riboswitch is
a noncoding RNA that regulates the expression of essential genes in many Gram-positive
bacteria (including pathogenic examples), thus making it a unique target for novel antibacterial
agents. A key component of the T-box riboswitch regulatory mechanism involves tRNA binding
to the highly conserved antiterminator RNA element--an excellent target for drug discovery. This
project will explore the rational design of allosteric modulators of T-box antiterminator RNA
function and compare their efficacy to that of competitive inhibitors. No therapeutic agents are
currently known to specifically target the T-box riboswitch.
This supplement request proposal seeks to replace a 14-year old microplate reader that is
failing. Replacement of this essential piece of equipment will enable us to fulfill the specific aims
of the parent award.
The proposed research is unchanged from the parent award where we planned to use
computational methods to design the next generation of compounds that inhibit T-box riboswitch
function, then synthesize and test them in high throughput screening assays followed by
characterization of RNA binding mode.
Achievement of the proposed specific aims of the parent award will improve scientific
knowledge by developing design strategies to identify inhibitors (including allosteric modulators)
of RNA function and by exploring the most effective chemical space features of these small
molecules. This information will be significant for antibacterial drug discovery targeting the T-box
riboswitch and also for the still emerging broader field of targeting noncoding regulatory RNA in
general for antibacterial, antiviral, anticancer and other drug discovery efforts. In the process, a
team of primarily undergraduate students will gain first-hand experience working on an
innovative drug discovery project that will inspire them to consider careers in biomedical
research.

Public health relevance
Project Narra+ve The increasing number of bacterial infec3ons which are resistant to current medicines is crea3ng a signiﬁcant threat to human health. This supplemental award will replace a malfunc3oning old instrument to help ensure the success of the parent award. In the parent award, a predominantly undergraduate research team will design, make and test molecules aimed at disrup3ng a unique regulator in bacteria. The outcomes from this project will help in the design and development of new an3bacterial medicines and will also lead to the training of future biomedical research scien3sts who are inspired to discover solu3ons for tomorrow’s public health.